Optimizing Mindfulness and Acceptance-Based Treatments for Bulimia Nervosa and Binge Eating Disorder using a Factorial Design

PROJECT SUMMARY
Cognitive Behavioral Therapy (CBT) is typically considered the current gold standard and first line treatment for
disorders characterized by recurrent binge eating such as bulimia nervosa (BN) and binge eating disorder
(BED). Outcomes, while clinically significant, leave substantial room for improvement with recent systematic
reviews and meta-analyses finding that 40-50% of patients with BED and nearly 70% of patients with BN remain
at least partially symptomatic after a full course of CBT. In an effort to improve outcomes, a growing number of
researchers have begun to evaluate the use of mindfulness and acceptance-based behavioral treatments
(MABTs) for BN and BED and preliminary evidence suggests such treatments can be effective for this
population. Although the research on MABTs for binge eating remains nascent, MABTs are frequently used in
clinical practice for BN and BED, with one recent study showing that patients are more likely to report that their
therapist has used mindfulness-based techniques than CBT-specific techniques.
Given the widespread clinical interest in MABTs and the growing body of research supporting the preliminary
efficacy of these treatments, a fully powered tests of the efficacy, mechanisms of action, and moderators of
outcome for MABT appears warranted. In particular, rather than testing any specific MABT treatment package
(e.g. acceptance and commitment therapy, dialectical behavioral therapy, mindfulness-based eating
interventions) in a large clinical trial, we believe that a study that can isolate and evaluate the independent and
synergistic efficacy of the most commonly used MABT components has the highest potential for impact. A
review of MABTs for BN and BED suggests that there are four commonly used MABT components: (1) Mindful
Awareness, (2) Distress Tolerance, (3) Emotion Modulation, and (4) Values-Based Decision Making. MABT
treatment packages have vary widely in which of these components they incorporated and which they
emphasized. By identifying which components of MABTs are most effective (and for whom they are effective),
we can emphasize the powerful elements of MABTs and deemphasize or eliminate inert components.
A traditional RCT would not provide the power necessary to evaluate the independent and synergistic efficacies
of four distinct treatment components compared to an active treatment approach such as CBT. Instead, the
proposed study will use a Multiphasic Optimization Strategy (MOST) approach (including a full factorial design)
in which 256 individuals with transdiagnostic binge eating pathology are assigned to one of sixteen behavioral
treatments, i.e., representing each permutation of the MABT component described above being included or
excluded from the base treatment (a version of CBT that emphasizes the key behavioral ingredients of this
treatment approach). Results of the component analysis set up future work to evaluate an optimized treatment
containing only effective components (which can be expected to have superior efficacy, efficiency and
disseminability) against current gold-standard CBT.

Public health relevance
PROJECT NARRATIVE Mindfulness and acceptance-based behavioral treatments (MABTs) for bulimia nervosa and binge eating disorder are a promising treatment approach that is widely used in standard clinical practice, but little is known about which specific MABT treatment components lead to improvements in disordered eating symptoms. The proposed study will use a Multiphasic Optimization Strategy (MOST) approach, including a full factorial design in which 256 individuals with transdiagnostic binge eating pathology are assigned to one of sixteen behavioral treatments, i.e., representing each permutation of four commonly used MABT component (Mindful Awareness, Distress Tolerance, Emotion Modulation and Values-Based Decision Making) being included or excluded from a standard behavioral treatment for transdiagnostic binge eating. Results of the proposed study set up future work to evaluate an optimized treatment containing only effective components (which can be expected to have superior efficacy, efficiency and disseminability) and will identify key moderators of treatment outcome to facilitate treatment matching.